Vascular regulation in postmenopausal females

Project Summary/Abstract
The goal of the proposed study is to elucidate mechanisms contributing to the heightened risk of
cardiovascular disease (CVD) and hypertension (HTN) in early-menopausal compared to typical-age-
menopausal females. The risks of CVD and HTN increase steeply after menopause, but females who complete
menopause early (< age 46 yrs.) are more likely to experience HTN and CVD-related morbidity and mortality
than those who complete menopause at a typical age (~ 51 yrs.) Furthermore, sympathetic increases in
females after menopause, and higher sympathetic drive is associated with cardiovascular mortality and HTN.
Postmenopausal females have shown dysregulation in autonomic control of blood pressure (BP), but it is
unknown whether BP dysregulation occurs similarly in early-menopausal and typical-age-menopausal females.
Moreover, altered vascular transduction, whereby an increase in sympathetic activity causes vasoconstriction,
may play a role in the development of HTN. This proposal will investigate sympathetic regulation of blood flow
and blood pressure in early- and typical-age-menopausal females. Additionally, individuals who are racialized
as non-white have higher cardiovascular risks than white people, and this study will explore perceived
discrimination and coping as potential mediators of CVD and HTN in postmenopausal females of diverse
backgrounds. To evaluate vascular regulation, forearm vascular conductance (FVC) and muscle sympathetic
nerve activity (MSNA) will be measured via venous occlusion plethysmography and microneurography,
respectively, in postmenopausal females, ages 50-70 yrs., who completed menopause early or at a typical
age. Conductance and MSNA will be measured at rest (SA1) and during a two-minute cold pressor test (CPT)
of the hand (SA2). Importantly, BP responses to a CPT can predict future HTN, and greater sympathetic
reactivity to a stressor may indicate a higher risk for future CVD. Further, physiological responses and
correlations between discrimination and coping scores will be explored (SA3). The hypotheses are that early-
menopausal females will have lower resting FVC and higher resting MSNA, and larger changes in FVC and
MSNA with CPT, than typical-age-menopausal females; and that higher perceived discrimination and lower
coping ability will be associated with higher sympathetic outflow. Dr. Lee will be trained in techniques of
microneurography and venous occlusion plethysmography and will engage in career development activities,
including grant and scholarship development. In addition, she will be trained in community-engagement
strategies during the fellowship duration. She will receive training from an exemplary team in a research-rich
environment within the Medical School at the University of Minnesota. This proposal aligns with the NHLBI’s
mission, identifying mechanisms contributing to HTN and CVD for development of prevention and treatment
strategies to reduce CVD risk in early-menopausal females, while also striving toward health equity. The
proposed study will provide foundational knowledge along with exceptional fellowship training for the applicant.

Public health relevance
Project Narrative Cardiovascular disease is the leading cause of death of females in the United States, and females experience a steep increase in cardiovascular disease risk after menopause; females who complete menopause early (before age 46 yrs.) have a higher risk of cardiovascular disease and hypertension than those who complete menopause at a typical age (~ 51 yrs.) The proposed study will investigate autonomic mechanisms underlying dysregulation of blood pressure in early- and typical-age-menopausal females of diverse backgrounds, thereby elucidating factors that contribute to adverse cardiovascular health outcomes associated with early menopause. Findings from this research will lay the groundwork for development of prophylactic and therapeutic approaches to reduce cardiovascular disease risk in postmenopausal females and specifically in early-menopausal females.